Special Projects Sample Collection

SC-DHEC PHL ? Sample Collection The South Carolina Department of Health and Environmental Control, Public Health Laboratory intends to work to enhance capacity and capabilities for food surveillance and foodborne outbreak response through the Laboratory Flexible Funding Cooperative Agreement. An increased number of surveillance samples are required under the Laboratory Flexible Funding Cooperative Agreement. South Carolina Food Microbiology Laboratory is requesting funds to support the purchasing of 200 human food and 250 animal food products. These products will be purchased by the SCDA through an interagency agreement. This agreement is already an established mechanism for the purchasing of food for surveillance purposes for samples collected under the Food and Drug Administration’s National Antibiotic Resistance Monitoring System (NARMS) cooperative agreement. As a member of the SC Rapid Response Team SCDA has the necessary training and experience to collect samples in accordance with FDA rules and regulations.